Workshop on Receptor-Binding Radiotracers 2003

[unreadable] DESCRIPTION (provided by applicant): The proposed Workshop will gather the leading experts within the field of receptor-binding radiotracers. Our objective will be to summarize the state of our art and to explore opportunities for future agents. Our goal is to repeat the format and success of the 2000 meeting held in La Jolla. Entitled Workshop for Receptor-Binding Radiotracers and sponsored by the DOE Office of Biological and Environmental Sciences, this meeting provided a small-group setting for colleagues to communicate at a level of detail that is not possible at typical scientific meetings. [unreadable] [unreadable] The scope of the Workshop will be multidisciplinary and include the synthetic chemistry, analytical biochemistry, and physical chemistry of receptor-binding agents. Fifteen of the twenty-one presentations apply directly to cancer imaging agents. Additionally, we will explore current and future imaging instrumentation. We will consider a wide spectrum of targeted agents: labeled small molecules, labeled DNA and RNA probes, and labeled antibodies. Lastly, we will discuss the application of these radiotracers as diagnostic agents in the clinic, as probes for drug development and as an analytical tool for investigation of human physiology. The participants will include radiochemists, mathematicians, biochemists, pharmacologists, physicists, nuclear physicians, and clinicians. In addition to research presentations using radioligands for receptors, we also will have research presentations using other imaging modalities in order to discuss the field of imaging from all aspects. [unreadable] [unreadable]